AIBP-mediated neuroprotection in glaucomatous optic neuropathy

Glaucoma is a leading cause of blindness worldwide and glia-driven neuroinflammation is a key element in the
pathogenesis of glaucoma. Increasing evidence from clinical studies indicate that primary open-angle glaucoma
is linked to single-nucleotide polymorphisms of toll-like receptor 4 (TLR4), mitochondrial cytochrome c oxidase
subunit I of the oxidative phosphorylation (OXPHOS) complex-IV, ATP-binding cassette transporter A1 and
Cholesterol-24S-hydroxylase, suggesting that TLR4-mediated neuroinflammation, cholesterol efflux and/or
OXPHOS stress-mediated mitochondrial dysfunction play roles in glaucoma pathogenesis. ApoA-I binding
protein (AIBP), encoded by the APOA1BP gene, is a secreted protein, which serves as a selective regulator of
cellular cholesterol metabolism, targeting inflammatory cells via its binding to TLR4. Cholesterol depletion from
inflammatory cells reduces lipid raft abundance and the membrane occupancy of receptors (such as TLR4) that
mediate inflammatory signaling. Emerging evidence from our group showed that AIBP deficiency is associated
with glia-driven inflammatory TLR4/interleukin-1β signaling axis and mitochondrial dysfunction in glaucomatous
degeneration. In addition to protecting retinal ganglion cells (RGCs) against neuroinflammation, AIBP prevents
RGC mitochondrial dysfunction in glaucomatous neurodegeneration. In preliminary studies, we demonstrated
that AIBP expression is highly reduced in glaucomatous human and mouse RGCs and their axons, as well as
Müller glia, and that amplification of retinal AIBP expression by adeno-associated virus delivery protects RGCs
and preserves visual function in experimental glaucoma in vivo. In addition, treatment with recombinant AIBP
protein promotes mitochondrial function in Müller glia against elevated pressure in vitro. Based on our previous
and these findings, we propose to test the novel concept that AIBP controls retinal neuroinflammation and the
RGC mitochondrial dysfunction, which lead to glaucomatous neurodegeneration, as well as to test the
therapeutic potential of raising AIBP expression in the retina. The Specific Aims of this proposal are: (1) to define
the mechanisms by which AIBP controls TLR4-lipid raft activation in inflammatory Müller glial cells; (2) to
determine the protective mechanisms of AIBP amplification on mitochondrial network and bioenergetics in
glaucomatous RGCs and Müller glial cells; and (3) to determine how therapeutic augmentation of AIBP
expression impacts structural integrity and synapses linking RGCs and the central visual pathway. Our proposed
studies will explore novel pathways which potentially link neuroinflammation regulation to elevated IOP-mediated
mitochondrial function and cellular cholesterol metabolism. This work may also lead to the development of a new
glaucoma therapy.

Public health relevance
PROJECT NARRATIVE Glaucoma is a complex, multifactorial disease characterized by a slow and progressive degeneration of the optic nerve, leading to visual impairment. Despite the widely appreciated disease relevance of neuroinflammation and mitochondrial dysfunction as critical pathogenic elements, the mechanisms underlying glia-mediated neuroinflammation and the contribution of compromised mitochondrial network and function in glaucoma remain unknown. The proposed study explores novel pathways of potential links between AIBP and neuroinflammation, cholesterol efflux and mitochondrial function, and develops new therapy for glaucoma